Probing the specific interactions of AlphaA- crystallin and its aging- and cataract-associated forms with lens cell membrane mimics

ABSTRACT
The human lens contains high concentrations of the molecular chaperones, alpha-crystallins
(ACs), that maintain lens transparency. AC consists of alphaA- (AAC) and alphaB- (ABC) crystallins, both
distinct proteins, broadly similar in structure and function. Upon aging and in age-related cataract (ARC),
AC is bound to the lens fiber cell membrane which leads to the loss of transparency. It is unclear which
of the two proteins (AAC or ABC) binds to the membrane, or if both do, and how; but the binding does
promote opacity. Therefore, to eventually delay or mitigate lens opacity it is important to first determine
the molecular basis underlying such binding. AAC is primarily lens specific − unlike ABC − and is present
at about three times higher concentration. There is more evidence implicating AAC than ABC in direct
membrane binding – therefore AAC is our focus here. The lens membrane is unique in composition, and
contains elevated levels of sphingomyelin (SM), dihydrosphingomyelin (DSM), and cholesterol. Aging-
related protein modifications and membrane compositional changes appear to result in a significant
increase in ACs binding to the membrane, especially in the population of AAC-containing intramolecular
disulfides (S-S). This raises the question: Do the well-known aging-related AAC modifications, i.e., (i)
truncation of C-terminal Ser (AAC-1-172), and (ii) deamidation of Asn 101 (AAC-N101D), or (iii) its “pre-
senile” cataract-associated G98R mutant, show increased membrane-binding relative to AAC? To
distinguish these processes, we hypothesize that AAC binds to SM (and DSM), aided by other
phospholipids (PLs), and modulated by cholesterol in the human lens membrane. The
disulfide-oxidized form of AAC may play a role in this process. For clearly defining the role of
individual membrane-lipid components, we will use liposomes (membrane mimics with defined
compositions) instead of human lens membranes, and recombinant human crystallins. For a
comprehensive understanding of the binding process, we will use targeted biophysical techniques: FTIR
(for SM, cholesterol, and protein); Raman (for −SH and SS bonds and bond strength); CD (for protein
conformation); solution NMR (for residue-specific structural information), and Langmuir balance (to
measure lipid-monolayer insertion by AAC). We propose the following specific aims:
1. Characterize AAC binding to the membrane and define the role of, (i) lipid composition, and (ii)
oxidized AAC in membrane binding. 2. Determine if (i) membrane binding increases in age-modified
AAC forms (AAC-1-172, & AAC-N101D), and (ii) the “pre-senile” G98R mutant; and if (iii) the oxidized
age-modified AAC forms play a role in membrane binding.

Public health relevance
PROJECT NARRATIVE Upon aging, nearly all the alpha-crystallins in the human eye lens eventually bind to the cell membrane leading to opacity and cataract formation. Age-related cataract has no cure at present. We subscribe to the hypothesis that primarily, alphaA-crystallin binds to the membrane. Using lens membrane mimics, we propose to examine the nature of this binding. We will also test the membrane-binding characteristics of age-related alphaA-crystallin modifications to understand how the binding process can be controlled to delay or mitigate lens opacity and age-related cataract.